Functionally dissecting MECOM gene regulation in high-risk leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is a devastating disease that continues to have a poor prognosis with less than
one-third of patients achieving a cure from their disease. While the identification of genomic subtypes has
enabled some risk stratification, it is increasingly evident that variation in cell states in AML and particularly the
presence of leukemia progenitors that co-opt hematopoietic stem cell (HSC) programs appear to confer a
particularly poor prognosis. Despite these robust descriptive observations, however, the molecular drivers of
these high-risk gene expression programs that alter cell state have remained largely undefined. Our research
group recently characterized a gene network that is regulated by the HSC master transcription factor MECOM
and co-opted in high-risk forms of AML. However, we still lack an understanding of the mechanisms by which
MECOM regulates this network and how it can be therapeutically hijacked to improve treatment of leukemias.
To better interrogate MECOM’s direct function in AML, we engineered an AML cell-line model in which MECOM
can be rapidly and controllably degraded by addition of a small molecule. Assessments of changes in
transcription and chromatin accessibility immediately following complete MECOM degradation implicate
MECOM as an epigenetic repressor of a pro-myeloid differentiation program. Importantly, the majority of these
differentially accessible chromatin regions are also directly bound by MECOM in the absence of degradation,
suggesting that these observed changes are a direct consequence of MECOM ablation. The observed repressive
function of MECOM is also consistent with its reported interactions with the CtBP family of co-repressive factors.
However, there are fundamental knowledge gaps both in the identity of MECOM’s direct targets across primary
AMLs and the mechanisms underlying its repressive function, both of which could be therapeutically useful. This
study consists of two aims to investigate: (1) the identity of genetic targets directly regulated by MECOM function
in high-risk AMLs, and (2) the epigenetic mechanisms by which MECOM represses differentiation programs to
maintain AML progenitor cells. For this F31 award, the PI has designed a research strategy and training program
that will provide him with: (1) fundamental expertise in genomics, bioinformatics, and cancer biology, (2) an
expert group of mentors and collaborators to promote not only research expertise, but also career-long academic
skills including grantsmanship and scientific communication, and (3) experience performing rigorous,
mechanistic and foundational biomedical research in preparation for his career goal as an academic scientist.
This proposal will take place in the rich and collaborative Harvard Medical School and Boston Children’s Hospital
research environments. Completion of this work is expected to identify the direct transcriptional targets of
MECOM in high-risk AML and elucidate the epigenetic mechanisms by which MECOM drives leukemogenesis.
These results will have profound implications for the rationale pursuit of high-confidence, tractable targets that
can be therapeutically manipulated for the treatment of myeloid malignancies currently with dismal outcomes.

Public health relevance
PROJECT NARRATIVE Master transcriptional regulators are critical for the proper function and maintenance of human stem cells. During blood cell production, dysregulation of the transcription factor MECOM can greatly disrupt normal differentiation of hematopoietic stem and progenitor cells and is thus implicated in aggressive forms of blood cancer. Here, I will use biochemical and genomic approaches to define the direct transcriptional targets of MECOM in acute myeloid leukemia and functionally dissect mechanisms by which MECOM exerts control over this gene regulatory network to ultimately elucidate novel therapeutic targets for the treatment of high-risk leukemias.